Advanced MRI of Spinal Cord Injury

Rationale and Preliminary Data: We will conduct a study of human spinal cord injury (SCI) to validate MRI
biomarkers of injury severity and prognostication of outcome using a novel diffusion MRI technique developed
specifically to detect axonal injury in the spinal cord. Predicting outcome from SCI has been a longstanding goal
for better clinical management and aiding in the development and testing of therapies. Traditional neurological
examination is not an accurate predictor of outcome, and conventional MRI, including T2-weighted imaging,
while useful for diagnosis, does not accurately predict the degree of recovery. Diffusion tensor imaging (DTI)
has shown promise as a prognostic imaging biomarker in SCI, but its clinical adoption has been hindered by
technical challenges and non-specificity to the underlying pathology. Our preclinical studies in a rat SCI model
have demonstrated that double diffusion encoding (DDE) MRI is sensitive to acute axonal injury and predicts
outcome with accuracy better than either DTI or traditional functional scoring. Likewise, recent developments
by our collaborative group have demonstrated the ability to employ diffusion contrast adjacent to metal surgical
hardware, which is prone to artifacts. While promising, validation of these technologies to simultaneously
improve contrast and quality is critical to advance the technology and ensure its utility in human subjects and
clinical settings. This project will translate these techniques to advance the understanding of the DTI changes
in the cord as markers of injury. Our hypotheses are 1) in the acute setting, DDE estimates of acute axonal
injury will predict long-term functional outcomes, and 2) in the chronic setting, DDE estimates of permanent
axonal loss will correlate with existing functional outcomes. It is predicted that DDE will outperform DTI,
conventional MRI, or functional neurological exams in SCI. To test this hypothesis, we will perform in vivo MRI
and functional assessments in the acute phase after traumatic spinal cord injury. In Aim 1, we will examine the
prognostic ability of DDE to predict later neurological recovery using follow-up functional assessments. In Aim
2, we will detail the link between axonal loss (sparing) as measured by DDE and permanent neurological function
after SCI. These studies seek to establish and validate DDE as a surrogate maker of injury severity and outcome
and compare it with existing clinical standards and established MRI indicators of SCI. We hypothesize based
on strong preclinical results that detection of microstructural injury using DDE will more accurately reflect the
degree of neurological impairment than MRI techniques non-specific to underlying pathology. The potential for
clinical translation is highlighted by DDE being a rapid acquisition of only a few minutes and requires minimal
post-processing or post-hoc analysis for quantification. Moreover, DDE enables visualization of the degree of
injury in individual subjects, making it promising for clinical management of SCI patients. Collectively, these
studies will establish and validate DDE as a biomarker of SCI with the potential to improve prognostication in
human SCI.

Public health relevance
Presently, more than 40,000 Veterans with spinal cord injury (SCI) are eligible for care under the Department of Veteran Affairs. Attempts at restoring neurological function for these Veterans remains a challenge, largely due to our limited understanding of the disease. The current proposal aims to translate a novel and promising spinal cord imaging technique to improve diagnosis and prognostication in SCI and investigate relationships with motor and sensory function along with other functional domains that have a direct impact of patient- reported quality of life. This data will be crucial to understanding the link between spinal cord structural integrity and function. The results of this study will help establish diffusion imaging as a non-invasive biomarker for SCI prognostication and offer newer approaches for monitoring therapeutic interventions in injured Veterans.